Neural Correlates of Recovery from Aphasia After Stroke

Project Summary/Abstract
Aphasia is one of the most common and debilitating consequences of stroke. Fortunately, most individuals with
aphasia after a stroke experience some degree of recovery of language function over time, which is thought to
depend on neural plasticity. The overall goals of the parent project are to better characterize the neural
correlates of recovery from aphasia after stroke, and to investigate which patterns of functional reorganization
are associated with the most favorable language outcomes. These goals are addressed in the context of a
longitudinal study of recovery from aphasia in the first year after stroke. This longitudinal study has generated
an extensive dataset of audiovisual recordings of speech and language evaluations in individuals with aphasia
at multiple timepoints, including connected speech samples. The majority of participants have consented to
sharing these valuable audiovisual recordings, and there are many potential benefits to sharing these data,
including research applications (e.g., different analyses of the data than those we planned) and clinical
education (e.g., the opportunity to listen to and watch individuals recover over time, with concurrent access to
their neuroimaging findings). Yet, there are substantial privacy concerns, because audiovisual recordings
which include voices and faces cannot be deidentified even in principle. In deciding how to balance
considerations about data sharing and patient privacy, it is critical to take into account the perspectives of
people with aphasia and their care partners. Ethical concerns surrounding the sharing of identifiable
audiovisual data, particularly in vulnerable populations such as individuals with aphasia, remain underexplored.
This administrative supplement explores the attitudes of individuals with aphasia and their care partners
towards sharing identifiable audiovisual data. Through thematic analysis of in-depth semi-structured interviews,
we aim to identify key themes and factors influencing attitudes towards data sharing in this population. We will
then analyze informed consent processes related to data sharing across multiple labs, and generate
recommendations for the ethical sharing of audiovisual speech and language data from individuals with
aphasia. This is a project specific to bioethics research, which aims to support the development of an evidence
base that may inform future policy directions. By understanding the attitudes of individuals with aphasia and
their care partners towards sharing identifiable audiovisual data, researchers and policymakers can develop
more ethical and inclusive data sharing practices.

Public health relevance
Project Narrative Aphasia (acquired language impairment) is one of the most common consequences of stroke and often leads to significant long-term disability. Audiovisual recordings of individuals with aphasia can provide rich information and are valuable for research and clinical education, yet the sharing of identifiable audiovisual data raises ethical concerns regarding privacy, confidentiality, and consent. This study will explore the attitudes of individuals with aphasia and their care partners towards sharing identifiable audiovisual data.